Deep Learning Serial Radiomics for Improved Cancer Therapy Response Assessment.

Summary
This Direct to Phase II SBIR proposal aims to further develop and validate a deep learning
radiomics biomarker for improved early response assessment in metastatic cancer therapy trials.
The motivation for this project stems from the high failure rate of oncology trials progressing from
Phase II to Phase III, with 25-30% advancing and 30-40% of Phase III trials ultimately failing. The
current standard for early therapy response assessment, Response Evaluation Criteria in Solid
Tumors (RECIST 1.1), faces challenges, particularly in early response evaluation due to delayed
tumor size changes and varied growth patterns from newer therapies. RECIST, being a
categorical metric, may not fully capture early changes, as supported by previous studies that
suggest more advanced metrics can provide better assessments.
The proposed project addresses the need for a more sensitive and automated biomarker that can
supplement RECIST in clinical trials. We propose a deep learning-based serial radiomics model
designed to predict overall survival more accurately than RECIST. Our proposed model takes as
input CT scans at baseline and at one or more follow up time points and outputs a continuous
serial CT response score (serialCTRS) representing the probability of overall survival. An
innovative aspect of our fully automated approach is that it uses the complete CT scans and
therefore learns response signals both within and outside of tumor regions.
A preliminary study was performed using a large real-world dataset of non small cell lung cancer
patients, demonstrating that the serialCTRS biomarker improved prediction of OS compared to
RECIST and compared to the percent change in tumor volume, including for therapy regimens
not seen during training. SerialCTRS also demonstrated improved assessment in an external
clinical trial dataset. The purpose of this project is to further develop and generalize the
serialCTRS biomarker and validate its utility for informing clinical trial decisions. The project aims
are:
Aim 1: Expand serialCTRS by incorporating diverse datasets, self-supervised learning,
multi-time point inputs, and explainability analyses;
Aim 2: Validate serialCTRS performance against held-out datasets, compare to RECIST
and other metrics, and demonstrate impact through simulated Phase II trials.
Successful completion will lead to a validated serialCTRS tool ready for commercialization to
improve clinical trial decisions, such as informing interim and futility analyses and informing the
decision of whether to advance a trial to Phase III.

Public health relevance
Narrative Global spending on clinical trials is approximately $200 billion, with oncology drug development accounting for about 45% of this total expenditure. However, despite this considerable investment, approximately 30-40% of Phase 3 oncology trials fail. These failures are largely due to the complex nature of cancer and the challenges in demonstrating both safety and efficacy in clinical trials. To address these costly failures, there is a growing focus on improving trial design and patient selection. Onc.AI is developing an automated imaging-based tool that is more prognostic of overall survival than current standard-of-care methods like RECIST. Our deep learning serial imaging tool offers more accurate and early predictions of treatment outcomes, streamlining the drug development process, reducing the risk of advancing ineffective treatments, and ultimately saving time and resources. Identifying the most promising therapies early on spares patients from unnecessary side effects associated with ineffective treatments thus improving their overall quality of care. By integrating this tool into clinical trials, Onc.AI not only aims to enhance the precision of early drug development but also to improve patient safety by ensuring that only the most promising therapies proceed to later stages. This approach aligns with the increasing demand in oncology to move beyond traditional response metrics and adopt more sophisticated, data-driven methods for evaluating new treatments.